Machining and Prototyping Research Core (MAPRO)

MAPRO Project Summary
For the Phase II COBRE, we are strategically positioned to propose the development of research
cores that will extend, enhance, and strengthen our COBRE infrastructure and research efforts.
Therefore, we propose to establish the Machining and Prototyping Research Core (MAPRO).
MAPRO will provide access to state of the art manufacturing equipment and highly skilled
personnel for the design, fabrication, and maintenance of cutting-edge research devices to
support human movement related research. Additionally, MAPRO will provide mentorship and
device design consulting to all investigators, especially for investigators who do not have specific
expertise in physical manufacturing or software development for custom devices used in human
subject research. This training is crucial for the progression of human subject research, as an
understanding of new technology is fundamental for a technology’s adoption. By definition,
performing innovative and impactful research requires tools and devices that do not already exist.
Recognizing the high reliance on multidisciplinary skills to create modern devices that involve
complex hardware, electronics, and software solutions, MAPRO offers expertise across the
spectrum of modern device design for investigators. The MAPRO Core has three aims: (1) To
provide centralized resources for the design and fabrication of custom research devices and
instrumentation. (2) To provide mentorship and training on cutting-edge manufacturing
equipment, techniques and software that can be used to create new and innovative research
devices and clinically translatable products. (3) To establish MAPRO as a leading resource for
the University of Nebraska at Omaha, Nebraska, the Great Plains, and beyond for the
development of new and innovative devices to treat and prevent movement related disorders.